EFFECT OF CHROMIUM ON GENE EXPRESSION IN VIVO

The overall objective of this research project is to understand the mechanism by which chromium(VI) compounds affect gene expression. The approaches we plan to use in attacking this problem are: (1) examine the ability of chromium(IV) to differentially affect gene expression in rats and chick embryos, two well-characterized, yet developmentally different, in vivo systems; (2) compare the effects of chromium(IV) on different types of genes, i.e., constitutive genes, tissue-specific genes, inducible genes, and quiescent genes; and (3) determine possible mutations in genes affected by chromium(IV). The long-range objective of this research project is to understand the mechanism by which chromium(IV) compounds act as carcinogens. We plan to test the hypothesis that chromium(IV) - induced DNA damage will adversely affect the expression of genes containing repetitive sequences and inducible genes. The specific aims of the proposed research are: (1) Determination of the effects of chromium(IV) - induced DNA damage in rat liver and kidney and in chick embryo liver and blood cells on the steady-state mRNA levels (using liquid hybridization) and rate of transcription (using nuclear "run-off" transcription) of specific genes in vivo. The genes which will be examined are: a. constitutive inducible genes - chick delta-aminolevulinate synthase, rat and chick cytochromes P-450, rat and chick metallothioneins, and rat glutathione S - transferases (contain repetitive sequences); b. constitutive noninducible gene - chick transferrin (contains repetitive sequences); c. oncongenes - rat ras, chick myc; and d. constitutive noninducible gene - rat and chick actin. (2) Determination of possible chromium(IV) - induced mutations in specific genes in vivo using amplification and hybridization mismatch analysis.